Steroid nuclear receptor coactivators in T cell differentiation

In human, uncontrolled pathogenic responses of IL-17+ cells are linked to various autoimmunity
such as multiple sclerosis, Colitis and even autism whereas defective IL-17+ cells impairs
protective immunity against infection by bacteria and fungus. IL-17 is produced from both
adaptive Th17 cells and innate lymphocytes that contribute to immune responses at different
phases. Effective control of the scale of Th17 responses is thus critical for treatment of above
immune dysfunction. SRC1 and SRC3 are the functional co-factors for RORt, the essential
transcription factor controlling Th17 function. Currently, poor understanding of the mechanisms
responsible for the function of these co-factors prevents the development of potent clinical
treatments to boost protective Th17 immunity against infection and repress pathogenic immunity
responsible for autoimmunity. The objective of this proposal is to determine the role of SRC1
and SRC3 in the regulation of T cell-mediated immunity. Our proposed study will lay the
foundation for understanding the fundamental role of SRC1 and SRC3 in adaptive T cells and
innate lymphocytes, which will facilitate the development of specific and effective
immunomodulatory therapies to boost protective immunity and suppress pathogenic IL-17+ cell-
mediated autoimmunity.

Public health relevance
Project Narrative This project is to understand the function of nuclear receptor co-activators, SRC1 and SRC3 in T cells. This study will facilitate the development of effective immunotherapies to boost protective Th17 immune responses against pathogens while impairing the pathogenic Th17 responses that cause autoimmunity.